IGF::OT::IGF COORDINATING CENTER CLINICAL TRIALS"OXYTOCIN FOR ALCOHOL USE DISORDER"TASK ORDER NO. 8 - HHSN275201400001I/HHSN27500008TITLE: OXYTOCIN FOR ALCOHOL USE DISORDERPERIOD OF PERFORMANC

Alcohol treatment clinical trials